Laboratory Flexible Funding Model (LFFM)

Missouri Department of Health and Senior Services
State Public Health Laboratory
Project Abstract for RFA-FD-25-007
Laboratory Flexible Funding Model
Purpose:
The Missouri Department of Health and Senior Services (DHSS) State Public Health Laboratory
(MSPHL) seeks FDA cooperative agreement funding to increase capability and capacity in food
testing areas where FDA has identified specific needs. The goals and outcomes of this
cooperative agreement include the following:
1. The MSPHL, in support of Missouri’s manufactured food regulatory programs (MFRPS),
will conduct testing of targeted food samples using validated test methods and a quality
management system.
2. The test results generated by the MSPHL will be shared with Missouri’s MFRPS program
and FDA partners.
3. The MSPHL will participate in small scale method development, method validation
research and matrix extensions as requested by FDA.
The expected outcome from the completion of the aims will be to protect the safety of the food
supply and further increase public health. This project will strengthen and improve the
collaboration of surveillance testing activities between the FDA, the Missouri MFRPS, and the
MSPHL. Thus, advancing a national integrated food safety system.
Page 1 of 1

Public health relevance
Missouri Department of Health and Senior Services State Public Health Laboratory Project Narrative for RFA-FD-25-007 Laboratory Flexible Funding Model Grant Narrative: The Missouri Department of Health and Senior Services (DHSS) State Public Health Laboratory (MSPHL) seeks FDA cooperative agreement funding to increase capability and capacity in food testing areas where FDA has identified specific needs. The expected outcome will be to protect the safety of the food supply and further increase public health. This grant will strengthen and improve the collaboration of surveillance testing activities between the FDA, the Missouri MFRPS, and the MSPHL. Thus, advancing a national integrated food safety system. Page 1 of 1